Community Outreach and Engagement

COMMUNITY OUTREACH AND ENGAGEMENT: PROJECT SUMMARY
The catchment area of Siteman Cancer Center (SCC) spans 82 counties across Missouri and
Illinois. The counties exhibit significantly different levels of health coverage and overall cancer
burden. Within the catchment area, 15% of the population live in a rural area, and 29% in a
Medically Underserved Area (MUA). Our catchment area as a whole carries a disproportionately
high cancer burden, with increased incidence of late stage diagnoses and a high cancer mortality.
In fact, a significant percentage of SCC catchment counties fall within the highest US quartile for
breast, lung, prostate, and colorectal cancer mortality. To address the cancer burden in our
catchment, SCC investigators have developed tailored educational materials, cancer-specific
community partnerships, a clinical trial participation monitoring system, and expanded clinical
services as part of SCC’s Comprehensive Outreach Strategy. SCC’s Community Outreach and
Engagement (COE) component builds on this foundation with the goal to sustain partnerships
and assure that all cancer patients and communities can benefit from clinical and scientific
advances. SCC’s COE component addresses and monitors differences among populations
across the catchment area, including geography (rural), access to services (medically
underserved areas), and their interaction. SCC’s COE component is organized into an Internal
Advisory Board (IAB); a Community Advisory Board (CAB); a Clinical Studies Outreach (CSO)
team; and six and one-half full-time equivalents staff. These groups work together to accomplish
the COE aims: (1) Monitor and evaluate the cancer burden and differences in cancer screening,
mortality, and morbidity rates; (2) Accelerate the implementation of outreach, education, and
clinical resources in collaboration with communities to reduce the cancer burden across
populations in the SCC catchment; and (3) Support research to reduce the cancer burden across
populations in the SCC catchment through: (3a) Support for community-based research, and (3b)
Continuous evaluation and education to promote clinical trial participation. To achieve these aims,
COE will build upon existing strong community and regional partnerships that have emanated
from SCC’s critical role as a provider and research center in our catchment area. By achieving
the above aims, SCC will ensure that the center is best addressing the impact of cancer in our
catchment and is developing a solid infrastructure for sustaining positive impacts and
strengthening translation of SCC research to clinical practice. Together, these aims work to
reduce the cancer burden in SCC’s catchment.